Delineating the synapse coordination pathway

PROJECT SUMMARY
All of brain function, from sensory perception to behavior, is derived from the pattern and properties of synaptic
connections found between billions of individual neurons. These synapses are found in diverse forms, but two
major classes exist: electrical and chemical synapses. While these classes are thought to be distinct
biochemical units, it is clear the development of both types is linked. For example, the disruption of electrical
synapses alters chemical synapse development resulting in a variety of behavioral defects, while perturbing
chemical synapses impacts electrical synapse form and function. A barrier in the field remains in
understanding how neurons coordinate the development of these distinct synapse types. Strikingly, emerging
evidence suggests that such synaptic coordination may be achieved by a concerted regulatory pathway. Our
work identifies the autism- and epilepsy-linked gene Neurobeachin as required for both electrical and chemical
synapse formation by binding the intracellular scaffolds of both types of synapses, which are necessary for
building functional synapses. Additionally, our preliminary work reveals that the disruption of Neurobeachin-
interacting molecules also results in defects in both electrical and chemical synapse formation. These pieces of
evidence begin to build a model wherein synapse coordination is achieved by a regulatory pathway that is
essential for both synapse types. Yet, a critical gap remains in understanding the full extent of the genetic
regulatory network that constitutes the synapse coordination pathway. Therefore, the goal of this project is to
identify the genes that regulate electrical and chemical synapse coordination in vivo using a genetically
accessible vertebrate model system. This proposal uses the zebrafish Mauthner circuit with its stereotyped
electrical and chemical synapses and unparalleled genetic and imaging accessibility to assess synaptic
coordination in vertebrates in vivo. In Aim1 we propose to identify candidate genes that coordinate electrical
and chemical synapse formation using our efficient CRISPR screening pipeline. In Aim2 we examine the
effects of candidate mutations on the formation and function of electrical and chemical synapses. Together, the
proposed studies will identify the genes required to coordinate electrical and chemical synapse formation in
vivo. This work has the potential to reveal a novel frontier in neuroscience, a pathway that coordinates
electrical and chemical synapse development.

Public health relevance
PROJECT NARRATIVE The human brain contains billions of neurons organized into neural circuits by synaptic connections, forming the basis for perception, thought, and behavior. This project examines the genetic framework that coordinates electrical and chemical synapse formation during development. Defects in genes that affect synaptic coordination are tied to autism, epilepsy, myopia, and other neurogenetic disorders, therefore expanding our understanding of their function will provide a foundation to treat complex neural disorders.